Rigid Preoccupations in Right Temporal Degeneration: Phenomenology and Neural Mechanisms

ABSTRACT
Some individuals with behavioral variant frontotemporal dementia (bvFTD) and semantic variant primary
progressive aphasia (svPPA) syndromes are known to develop an intense, narrowed focus on specific activities,
interests, and ideas, which together can be termed “rigid preoccupations” (RP). Examples of these behaviors
include preoccupation with puzzles or games, collecting objects, dietary and exercise fads, religious or political
adherence, clock watching, preoccupation with saving gasoline or electricity, and many others. Despite the very
high early prevalence rates and clinical significance of RP behaviors in a subset of persons with dementia (PWD),
particularly those with right temporal lobe dysfunction where RP symptom rates approach 90%, there is still no
consensus in the field on the precise phenomenology of RPs from a behavioral neurology or neuropsychological
perspective, and thus no agreement on how to measure them. The absence of validated measurement tools for
comprehensively characterizing RP-related symptoms, and a lack of understanding of the fundamental neural
circuitry involved in different presentations of this behavior, have hampered diagnosis and phenotyping, clinical
research, clinical trial recruitment and monitoring, and clinical care of PWDs. For this study, we propose to
perform a comprehensive evaluation of the phenomenology of RP symptoms using qualitative ethnographic
methods, and to perform a chart review of archival research reports that can be analyzed in conjunction with
functional MRI data. This work will set the foundation for later development of neurologically-grounded measures
of RPs after this project. For Aim 1, we will perform a qualitative study to clarify the phenomenology of RPs
using standard ethnographic methods. We will enroll 30 PWDs known to engage in RP behaviors, and will
conduct interviews and home-based participant observation with them and their caregivers to elucidate their
motivating emotions and thought processes. Interviewers will take observational field notes and conduct
qualitative interviews with both PWDs and caregivers. Analytic memos will be constructed for each dyad to guide
identification of themes. Transcribed interviews and field notes will be coded in ATLAS.ti, adding new codes as
they emerge inductively. In parallel for Aim 2, we will perform a retrospective chart review of research visit
summary reports from 200 PWDs (100 bvFTD/100 svPPA), quantifying evidence of RP behaviors and their
associated cognitive and emotional processes. Data from the chart review will then be analyzed in conjunction
with previously collected resting-state MRI scans to perform a preliminary examination of the neural basis of RP-
associated features using functional connectivity and dynamic causal modeling approaches. Our goal is to
understand the phenomenology of RP behavior in a data-driven manner using mixed-method approaches robust
enough to capture the complexity of the internal cognitive and emotional processes involved, which will facilitate
more meaningful hypotheses about the neurologic mechanisms underlying RPs and guide development of better
measurement tools, facilitating advances in both research and clinical care.

Public health relevance
NARRATIVE By developing our understanding of the clinical manifestations and underlying network mechanisms of “rigid preoccupation” behaviors, an understudied but highly prevalent and disruptive symptom in persons with dementia due to neurodegenerative disease, we will have gained key information that can be used to improve measurement and tracking of this symptom in patients. Validated, neurologically-driven measures of behavior are required to run effective clinical trials for new dementia treatments. This study will also provide new information about how specific brain circuits malfunction to cause rigid preoccupation behaviors in persons with dementia, which will be more broadly applicable to other neurologic and psychiatric disorders.